Administrative Core

CORE SUMMARY
The Administrative Core will provide dedicated and effective administrative management as well as biostatistical
support to the Program Project. The overall goal is to facilitate collaborative and innovative cancer research
through strong scientific, operational, and financial management of Program resources. The primary functions
of the Administrative Core are to provide organizational and administrative management, including scientific and
fiscal management appropriate for this proposed Program and to ensure proper data sharing between Program
members. The Core will monitor and track all expenditures and ensure accurate allocation of funds; provide
logistics support for other aspects including personnel actions, IACUC documents, record keeping, progress
reports, arrange and coordinate meetings of the Program leaders and investigators, including travel. The Core
will also provide coordination and continuity between Icahn School of Medicine at Mount Sinai (ISMMS),
Columbia University (CU), Massachusetts Institute of Technology (MIT), and Sloan Kettering Institute (SKI)
performance sites for the duration of the Program. In addition, the Core will provide biostatistical support for all
four Projects. Dr. James Manfredi, Professor at the Departments of Oncological Sciences at ISMMS, will lead
the Core. Ed Hicks, MBA, MA will provide day-to-day administrative, financial, and operational oversight. Ms.
Amanda Caba will provide general administrative assistance to all Program members. Dr. Himanshu Joshi
will provide appropriate biostatistical support to ensure experimental design is sound and findings are
reproducible and rigorous. An External Advisory Board consisting of four leaders in the fields of p53 and
metastasis will provide essential scientific advice. Each year, the Administrative Core will organize a retreat for
Program members as well as a workshop on Mutant p53 which will be open to scientists outside the Program as
well. The goal is to not only facilitate the success of the Program but also ensure that science developed by the
Program will be shared with the greater scientific community.

Public health relevance
CORE NARRATIVE The Administrative Core will ensure that planned studies within the Program are successfully carried out with rigor and reproducibility and resulting findings are appropriately disseminated.